High-throughput measurement of neuronal projections and synapses using Synapse-seq

SUMMARY
The brain is composed of thousands of highly specialized cell types that form very specific
synaptic connections with each other. Together, these connections form neural circuits that are
the structural basis of brain function. Despite their importance, synaptic connections amongst
cell types are largely unascertained, because of the dearth of existing tools to do so. In this
project, we will develop a suite of genomics-based tools--collectively termed Synapse-seq--that
allow us to quantify neuronal projections, postsynaptic densities, and synaptic connections in
individual cells in vivo. First, we will use AAV to introduce a molecular tool that trafficks a
barcoded mRNA reporter to the presynaptic compartments of infected cells, combined with
single-cell sequencing and spatial transcriptomics (Slide-seq) to jointly match cell body positions
to projection targets. Next, we will use a postsynaptic targeting system, also delivered by AAV,
combined with synaptosome preparations and in situ sequencing to quantify spine densities
across thousands of single cells. Finally, we will combine our pre- and postsynaptic labeling
systems with novel in situ sequencing readouts to measure synaptic connectivity in vivo.
Together, the successful development of these technologies will provide neuroscientists with a
suite of powerful tools to routinely measure fundamental aspects of neural connectivity in vivo.

Public health relevance
NARRATIVE The synaptic connections between neurons are formed in a highly specific and stereotyped manner during development, and are the defining structural unit by which nervous systems function. Currently, synapses between cell types are largely unknown, because of the lack of technology to routinely and easily measure synapses between single cells. This work addresses this critical gap, using genomics-based barcoding tools to measure synaptic connectivity within single cells in mammalian brains.